Large-Scale Conformational Changes in Regulation of Transcription Initiation

[unreadable] DESCRIPTION (provided by applicant): Transcription initiation by DNA-dependent RNA polymerases (RNAP) at promoter DNA sequences involves large-scale conformational changes driven by binding free energy. The long term goal of this research on the representative E, coli enzyme is to characterize the sequence of these conformational changes and to determine their roles in creating the transcription bubble and active site for RNA synthesis. In the next project period, kinetic studies of association and dissociation will be performed in concert with low resolution structural characterizations (chemical and enzymatic footprinting; fluorescence resonance energy transfer (FRET)) to determine what conformational changes occur in each step, and how each sets the stage for the next. Key specific aims include elucidating how wrapping of nonspecific DNA sequences 60-80 base pairs upstream from the start site greatly accelerates open complex formation, and identifying when rearrangements in key regions of RNA polymerase (e.g. ejection of sigma70 masking domain from the active site channel, folding of unstructured regions of polymerase) occur. To this end, open complex formation by wild type and deletion polymerase mutants at promoter variants that delete upstream or downstream sequences will be characterized. Significant but simpler systems exhibiting analogous large-scale conformational changes will be studied in parallel: specific binding of 2 transcription factors (lac repressor dimer headpiece, IHF); and nonspecific binding of 2 nucleoid proteins (HU, IHF). Effects of temperature and solution variables on the thermodynamics of formation of a wrapped IHF-H' DNA interface will be measured by isothermal titration calorimetry (ITC) and FRET to obtain and interpret the thermodynamic signatures of DNA wrapping. Roles of multiple binding modes and cooperativity in nonspecific binding of HU will be determined using ITC. Coupling of local folding and formation of protein interfaces to operator binding will be investigated for the crosslinked dimeric headpiece by ITC, circular dichroism and a competitive nitrocellulose filter assay with intact lac repressor tetramer. Advances in the understanding of the mechanism of transcription initiation impacts 2 main areas of human health. First, understanding how transcriptional networks respond to developmental and environmental cues is fundamental to identifying and addressing failures in regulation that cause human diseases such as cancer. Secondly, human illnesses caused by bacterial infection (e.g. tuberculosis) wreak havoc on public health. Results generated by this proposal will define bacteria-specific aspects of initiation, and thus, reveal novel targets for the next generation of antibiotics. [unreadable] [unreadable] [unreadable]